Siyakhula: Growing HIV/TB Research Knowledge for Growing Healthy Kids in Eswatini

Program Summary/Abstract
The Eswatini-Baylor Children’s Foundation, University of of Eswatini (UNESWA) and Baylor College of
Medicine will conduct health research training in HIV and Tuberculosis (TB) induced premature aging in
conjunction with the existing D43 “Siyakhula” training program. Supplemental funds will support integration of
premature aging research training within all aspects of Siyakhula including mentorship, pilot project
development and implementation, and implementation of novel methods to measure and document post-
infectious premature aging. The additional training will be seamlessly integrated into the existing conference
series and applied research training program and introduce additional complementary capacity building
activities.
Despite successful antiretrovirals for HIV/AIDS and despite successful antibiotics for TB, there remains
increased morbidity and mortality and 5-12 years of premature aging. This one year supplemental funding
proposal will collaborate with researchers in Tanzania (Drs. Mkunde Chachage and Lucy Mrema) to share their
experiences and mentor Eswatini researchers in inflammaging and the detrimental bidirectional effects on
diabetes and HIV on premature aging. Dr. Fred Moonga (UNESWA) will provide lectures and mentorship on
social factors leading to premature aging. From BCM, Drs. Moran and DiNardo will provide lectures and
mentorship in nutrition across the lifespan and epigenetic mechanisms of premature aging, respectively.
The supplement will fund five to eight of the top pilot projects to help train Eswatini researchers in HIV induced
premature aging-related projects. Key projects will be chosen to focus on integrating HIV/AIDS with non-
communicable diseases, to document the ill effects of premature aging. Similarly, key projects that help
transfer technology to measure premature epigenetic aging (telomere qPCR, DNA methylation) or document
the ill effects between malnutrition and premature aging (cutaneous carotenoid or mass-spectroscopy based
nutritional methods). The projects will address the multidimensional means by which HIV/AIDS and TB induce
premature aging, and train Eswatini researchers how to measure and begin to mitigate premature aging.

Public health relevance
Project Narrative Baylor College of Medicine and the eSwatini Health and Human Subjects Research Review Board (EHHRRB), in collaboration with the eSwatini Ministry of Health, including the National Health Research and Innovation Department (NHRID), will conduct research ethics training in ‘decolonizing global health’ to raise awareness of the impact of colonialism on local health research practices and identify locally appropriate and responsive policy solutions to these challenges. Training will be seamlessly integrated into the existing noon conference series and applied research training program and introduce additional complementary capacity building activities. Building on earlier bioethics training with an anti-colonial emphasis, we will enhance in-country bioethics research capacity through a pre-conference workshop, a high-level roadmap creation round table discussion series and a consultative process to develop a locally adapted Good Clinical Practice curriculum concept note, aimed at strengthening bioethics research capacity in eSwatini, specifically as it relates to ‘decolonizing global health’ in the unique context of eSwatini and its’ efforts to combat the TB and HIV syndemic.